Novel Stimulation Patterns to Improve the Effectiveness of Spinal Cord Stimulation

Project Summary
Spinal cord stimulation (SCS) is a nonpharmacological intervention for the treatment of chronic pain. Importantly,
SCS may be more effective than opioids for pain relief and has been demonstrated to reduce opioid misuse in
pain patients. Current SCS therapy uses time-invariant pulses (TIP), which is based on stimulation with fixed
parameter pulse trains. However, SCS based on TIP stimulation has two critical challenges: 1) limited ability to
contour the location and quality of the paresthesia coverage and 2) loss of treatment effect due to tolerance.
To overcome these challenges, we propose the use of novel stimulation time variant pulse (TVPs) patterns, in
which a stimulation parameter changes according to a modulatory time-varying function. TVPs may provide
better therapy than TIPs in two ways. First, TVPs can change the recruitment of dorsal column fibers on a pulse
by pulse basis in a way impossible via TIPs. Support for this comes from our pilot pre-clinical study in which we
demonstrated that TVPs can generate dorsal column evoked compound action potentials (ECAPs) whose
morphologies vary with the applied TVPs. Second, the time-varying nature of TVPs may produce better sensory
encoding compared to TIPs. Support for this comes from preliminary results from our own and an independent
pilot, acute clinical study suggesting that TVPs can produce dynamic, enhanced coverage of the painful region
and improved perceived sensations in chronic pain patients.
Our central hypotheses is that TVPs can improve outcomes for SCS by enhancing paresthesia coverage and
reducing tolerance by varying spatial neuronal recruitment. In this proposal, we will develop devices capable of
delivering TVPs and perform long-term clinical testing in chronic pain patients to define the role of TVP SCS in
the management of intractable chronic pain. In this study, we will develop the firmware and software to deliver
TVPs, and obtain IRB and IDE approval for a clinical study using an implantable pulse generator capable of
delivering TVPs (Aim 1/UG3). Then, we will conduct a First in Human feasibility study with a double-blind,
randomized-controlled design (Aim 2/UH3), to determine the extent to which SCS TVP can reduce pain and
disability.

Public health relevance
Project Narrative Spinal cord stimulation (SCS) is a promising nonpharmacological intervention for the treatment of chronic pain. Current technology for SCS is based on time-invariant pulses (TIP) which can constrain the location and quality of paresthesia coverage, and contribute to the development of tolerance to the therapy. To overcome these challenges, we propose to develop and clinically test a device capable of delivering novel stimulation time variant pulse (TVPs) patterns, in which a stimulation parameter changes according to a modulatory time- varying function, a strategy which may lead to improved long-term pain outcomes with SCS.